Training Program in Mechanisms of Virus-Host Interactions

Summary:
The Icahn School of Medicine at Mount Sinai (ISMMS) Mechanism of Virus-Host
Interactions Training Grant is a multidisciplinary training program designed to train and
educate pre-doctoral and post-doctoral trainees in the broad discipline of Virology. The
proposal requests continued support for years 26-30 of the Virology Training Program The
faculty is derived from the three different departments at ISMMS with Dr. Domenico
Tortorella as the Program Director and Dr. Viviana Simon as the Co-Director. The
research training emphasis is directed toward teaching pre-doctoral and post-doctoral
trainees the theory and experimental approaches required for independent scientific
investigations. Trainees learn the molecular mechanisms involved in virus replication and
host responses to viral infections. Research training areas also include novel approaches
for antiviral strategies and vaccine development against medically relevant viruses. Our
trainees are highly successful in attaining independent research positions, peer-reviewed
publications, and extramural research funding. Accordingly, the Training Program is
requesting support for four pre-doctoral and three post-doctoral trainees per year under
the mentorship of 24 faculty Mentors. The specific aim of the program is to provide rigorous
training to high caliber students and fellows. The continued support of this program will
aid trainees in all phases of their development including understanding scientific method,
interpretation of results, presentation of data and conclusions, research ethics, and career
guidance. By combining the strengths of an outstanding group of Faculty Mentors, we
have created a world-class virology Training Program. This program is built upon existing
collaborations, including research grants, and joint publications between faculty members
at ISMMS. The program faculty consists of outstanding scientists who use a diverse array
of experimental strategies to study the molecular, cellular, biochemical, and immunological
interactions of viruses with their hosts and the development of viral therapeutics and
vaccines against viral pathogens. The Training program is expected to support 22-25
predoctoral and 12-15 post-doctoral trainees for 1-2 years. Trainees are expected to
complete training in 5 years as pre-doctoral trainees and 3-4 years for post-doctoral
trainees, obtain research-related positions in academia or industry, and publish at least
one first author manuscripts. These are achievable goals based on the rigorous Training
Plan and qualifications of the supported Trainees.

Public health relevance
Narrative The Mechanisms of Virus-Host Interactions Training Grant is vital to the development of the next generation of virologists. The trainees will be leaders in the field of Virology developing strategies to prevent and limit virus pathogenesis of viral diseases and the potential pandemics.